EFFECTS OF LIPID LOWERING ON CORONARY INTIMAL STRUCTURE AND ENDOTHELIAL FUNCTION

The primary objective of this investigtion is to assess the changes of coronary intimal structure and endothelial function in response to three different lipid-lowering therapies in patients with known coronary artery disease (CAD) and hyperlipidemia.